Enhancing Measures of Trunk Function in those with Physical Impairment

Trunk function is an important aspect of overall physical function. Measuring trunk function can
be challenging, and currently, there is not a widely adopted assessment that is precise, easily
administered, and inexpensive. The proposed projects aims to evaluate the Volume of Action
Score (VoAS) and Trunk Stability Score (TSS) as assessments of trunk function. 120 individuals
(40 with disability, 80 without disability) will be evaluated utilizing each test. Their scores will be
correlated to the PROMIS Short Form for Physical Activity, surface electromyography,
kinematics, and pressure produced at the foot. The findings of the study will result in an
understanding of how trunk function impacts the ability to move and stabilize the trunk. VoAS
and TSS of the individuals without disabilities will be used to begin developing norms for these
tests.

Public health relevance
Project Narrative We propose to measure trunk function in those with physical disability using novel tests. The proposed tests are the Volume of Action Score and the Trunk Stability Score. They evaluate limits of stability and the ability to resist an outside force respectively. These test build upon current methods to create precise measures that give more robust information related to functional outcomes. We plan evaluate the relationships of these measures to other functional measures and related factors.